Prevalence and Associations of Protracted Torture-Related Physical Pain, Hypertension, and Stroke History in Refugees: A Longitudinal Cohort Study

PROJECT SUMMARY AND ABSTRACT.
We will establish a cohort of 250 globally representative adult refugees who are >10 years post-torture and
follow them for 24 months to: (1) Determine the prevalence of protracted torture-related physical pain, and
(2) Determine the prevalence of hypertension and stroke history in refugees with protracted torture-related
physical pain. We will characterize the associations of protracted torture-related physical pain, hypertension,
and stroke history with factors related to pain, mental health, and social determinants of health. Our long-term
goal is to improve the evidence-based clinical care of refugee torture survivors. Our primary objective here is to
determine the prevalence of protracted torture-related physical pain, hypertension, and stroke history in
refugee torture survivors. We evaluate a global population of refugees at our medical-legal clinic and are one
of the only such clinics in the U.S. with NIH-funded investigators. We have a 10+ year track record of refugee
health research, including the successful feasibility study for the Aims proposed here.
Aim 1. Determine the prevalence of protracted torture-related physical pain in refugees. Our preliminary
data indicate that torture-related pain may persist for >10 years. Hypothesis: >75% of refugee torture survivors
experience protracted (i.e., >10 years) torture-related physical pain. In our cohort of 250, we will assess pain
using a physical exam (PE) and the validated Brief Pain Inventory Short Form (BPISF), and time since torture
using the standard United Nations Istanbul Protocol. At baseline, 12-, and 24-months, we will characterize the
associations of protracted torture-related physical pain with factors related to pain (i.e., mechanism of injury,
pain type, time since torture, BMI), mental health (validated Harvard Trauma Questionnaire (HTQ)/Hopkins
Symptoms Checklist (HSCL) for posttraumatic stress, depression, anxiety), and social determinants of health
(SDOH, validated PRAPARE protocol, e.g., legal status, insurance, sex, origin country, time since U.S. arrival).
Aim 2. Determine the prevalence of hypertension and stroke history in refugees with protracted
torture-related physical pain. Our preliminary data in refugees with chronic pain after torture found a high
burden of HTN and stroke history, despite their young age. Hypothesis: In refugees with protracted torture-
related physical pain, at least 30% will have American Heart Association (AHA)-defined HTN and/or stroke
history. In cohort participants with protracted torture-related physical pain, we will assess HTN using AHA-
defined cutoffs and stroke history using the validated Questionnaire to Verify Stroke Free Status. At baseline,
12-, and 24-months, we will characterize the associations of HTN and stroke history with factors related to
pain, mental health, and SDOH. We will control for ASCVD risk factors (e.g., dyslipidemia, smoking, BMI).
IMPACT. Millions of refugee torture survivors reside in the U.S. However, evidence to guide care is lacking.
This first-in-kind cohort will establish critical knowledge on modifiable or preventable illness in refugees, and in
others with complex pain such as sexual assault survivors and U.S. veterans.

Public health relevance
PROJECT NARRATIVE. Of the >115 million refugees worldwide who are forcibly displaced as a result of war, violence, or persecution, nearly half have experienced torture. In this study, we will establish a cohort of 250 globally representative US adult refugees who are >10 years post-torture and follow them for 24 months to determine the prevalence of protracted torture-related physical pain (Aim 1), determine the prevalence of hypertension and stroke history in refugees with protracted torture-related physical pain (Aim 2), and characterize the associations of these diseases with factors related to pain, mental health, and social determinants of health. Findings from this study have immediate public health relevance given accelerating global violence and the resultant exponential rise of refugee men, women, and children, and are central to the NIH mission to advance scientific knowledge to improve health, extend life, and reduce illness and disability, in millions of refugees within the US and throughout the world, and millions of other young, at-risk people who live with complex pain, such as sexual assault survivors and military veterans.